UNDERGRADUATE RESEARCH TRAINING

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. I am currently training in the LFD learning different lab techniques including RICS analysis, cell migration, cell passaging as well as learning the use of different instruments such as the Zeiss and Olympus convocal microscopes. This also includes proper lab techniques and safety.